Rutgers Center for Environmental Exposure and Disease (CEED)

OVERALL – ABSTRACT
The Center for Environmental Exposures and Disease (CEED) at Rutgers University is a recognized leader in
New Jersey (NJ) - the most densely populated state in the Union, with many of its residents living in close
proximity to major congested roadways, and industrial and commercial centers. NJ is also the home of more
Superfund sites than any other state due to a long history of poorly regulated industry, as well as active efforts
to identify contamination. Over 85% of the state’s land area is already ‘built-out’ or preserved, meaning there will
soon be no remaining undeveloped land. Thus, NJ is a microcosm that reflects the longstanding and emerging
environmental problems confronting the entire nation. The strategic vision of CEED is to address the
environmental health concerns of all NJ residents by centering our efforts on its most affected populations. We
aim to accomplish our strategic vision by engaging community members, organizations, and agencies as
advisors and partners through all stages of our research, providing critical investment and infrastructure for
multidisciplinary collaborative research, and training the next generation of environmental health scientists. Our
approach to achieve this vision is to identify and prioritize the most urgent and hazardous environmental health
concerns of community members through an engaged community advisory board and community-driven
research initiatives that are integrated with the innovative translational research of CEED scientists. Over the
next five years, CEED will confront environmental health-related disease by working with affected communities
at the center of our efforts. Through bidirectional partnerships, rigorous science and training, cutting edge
technologies, and effective communication, CEED will work to reduce health risks and disparities within NJ, and
thereby improve public health across the state, the region, and the world.

Public health relevance
OVERALL - NARRATIVE The Center for Environmental Exposures and Disease (CEED) at Rutgers University aims to address the environmental health concerns of NJ residents by centering efforts on the most affected communities within the state. We will accomplish this by engaging community members, organizations, and agencies as advisors and partners through all stages of research, providing critical investment and infrastructure for multidisciplinary collaborative research, and training the next generation of environmental health scientists.